Columbia Population Research Center - Administrative Core

Abstract – Administrative Core
The Columbia Population Research Center (CPRC) administrative core (AC), led by center co-directors
Jennifer S. Hirsch and Jane Waldfogel, oversees, coordinates, and supports all of CPRC's activities, including
those provided through the development core, the computing and methods core, and the four primary research
areas (PRAs). The AC's specific aims are to: 1) manage and coordinate all of the center's activities; 2) provide
ongoing fiscal, strategic, and substantive oversight to the center; 3) facilitate communication: i. among CPRC's
cross-campus intellectual community, ii. between CPRC and the broader university, and iii. with select partner
institutions and the broader public; and 4) ensure appropriate access to computing and methods core and
development core services for junior scientists. By ensuring that all CPRC components function smoothly
together, providing administrative support for the computing and methods core and the development core, and
providing targeted help with proposal development (e.g. help with locating research assistants), the
administrative core anchors CPRC's work to maximize the efficiency and impact of population science at
Columbia.